SULFUR XANES STUDIES OF TAURINE IN ASTROCYTES AND NEURONS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Sulfur XANES will be determine the chemical speciation of the major sulfur species in intact astrocytes and neurons, and to follow the changes in speciation that accompany osmotic stress or treatment with glutamate.